Noninvasive bladder cancer diagnostics via machine learning analysis of nanoscale surface images of epithelial cells extracted from voided urine samples

PROJECT SUMMARY/ABSTRACT
Bladder cancer is common cancer with an estimated 81,190 new cases and 17,240 deaths in 2018 (with >
500,000 survivors) only in the US. The gold standard for diagnosis of bladder cancer includes an invasive
optical bladder examination (cystoscopy) and tumor resection for pathology examination. Because of a high
recurrence rate of this cancer (50-80%), frequent (once every 3-6-12 months) costly and invasive cystoscopy
exams are required to monitor patients for recurrence and/or progression to a more advanced stage. It makes
bladder cancer the most expensive cancer to monitor/follow up and treat per patient. Moreover, the invasive
nature of the current standard of care, cystoscopy, causes rather low compliance of patient to follow this
procedure. There is an urgent unmet need for a bladder cancer screening and monitoring test, which will be
noninvasive, rapid, objective, reproducible, easy to perform and interpret, and highly accurate. Such a test will
reduce the need in frequent cystoscopies and greatly expand the participation of patients in screening and
early detection programs because it decreases the patient discomfort and post-procedural complications.
Here we propose to develop such a test for identification of the presence of bladder cancer and its
aggressiveness (grade). It will be based on non-invasive analysis of individual cells extracted from urine
(extraction technology already exists in hospitals for voided urine cytology tests, (VUC) the current standard-of-
care, a non-invasive examination of cells in urine used to assist with cancer diagnosis and surveillance). A
novel modality of Atomic Force Microscopy (AFM) will be used for nanoscale imaging of cells extracted from
urine, mapping/imaging of the physical properties of the cell surface. The collected images will further be
analyzed using machine-learning methods and novel advanced statistical approaches to identify a “digital
signature” of cancer. The proposed technology is fundamentally different from previously studied urine
biomarkers and all existing physical methods because it is based on the analysis of physical properties of the
cell surface, not cell bulk or presence of biochemical markers or genetic analysis.
Our strong preliminary results demonstrate the feasibility of the proposed approach, its presumed
superiority compared to the currently used non-invasive methods, and lead us to the central hypothesis that
bladder cancer can be identified by analyzing a small number of cells randomly chosen from urine samples,
with a low sampling error. This is a substantial departure from VUC tests, which require a visual analysis of
many cells. Supported by the preliminary data, we propose (1) to optimize and expand the method, (2) to
define the accuracy of cancer detection on a large cohort of patients, and (3) to assess the accuracy of
identification of aggressiveness (low versus high grade) of bladder cancer.
Our long-term goal is to develop a non-invasive clinical method for accurate detecting of presence and
monitoring bladder cancer as well as many other cancers, in which cells can be extracted from easily
accessible bodily fluids without the need for tissue biopsy (e.g urine-bladder & upper urinary tract cancer, stool-
colorectal cancer, sputum-aerodigestive cancer, cervical smears-cervical cancer etc.), using methods based
on the analysis of physical characteristics of the cell surface. The proposed research, which is the first step in
pursuit of this overarching goal.

Public health relevance
NARRATIVE The goal of this proposal is to develop a novel, noninvasive, and sensitive bladder cancer screening test using cells found in voided urine samples that are imaged with ultra-high-resolution atomic force microscopy. The proposed method will improve the current standard-of-care cytological evaluation of voided urine test (VUC) to detect bladder cancer with higher accuracy, and further help to identify the grade of cancer. We anticipate this innovative technology will remarkably improve patient participation for screening and follow-up on bladder cancer, and confidently nominate patients for the more invasive and expensive detection using cystoscopies.